Training in the Molecular Basis of Autoimmunity and Autoinflammation

PROJECT ABSTRACT
Research over the past two decades has led to the discovery of mutations that cause rare autoinflammatory
diseases and advanced our understanding of common autoimmune diseases. Further, the understanding of the
complex mechanisms underlying autoinflammatory and autoimmune diseases has also expanded at a rapid
pace. We now have a better understanding of the interplay between key components of innate and adaptive
immune systems and the pathways involved. These advances were driven by improvements in sequencing
technologies, single-cell genomic approaches, spatial transcriptomics, proteomics, metabolomics, and high-
resolution imaging. Additionally, improved animal models of human disease, innovative stem cell and organoid
systems, and a new appreciation for the microbiome's influence on immune reactivity have fueled progress.
These discoveries provide a framework for identifying new targets to treat a wide range of autoimmune and
inflammatory diseases. Despite these advances, immune-mediated diseases are reaching epidemic proportions.
To address this emerging health crisis, we must train the next generation of scientists to capitalize on these
insights and develop novel therapeutic strategies for autoinflammatory and autoimmune diseases.
The Training in the Molecular Basis of Autoimmunity and Autoinflammation (AATG) T32 prepares predoctoral
students to become future scientific leaders by providing a strong foundation in the basic principles of innate and
adaptive immunity. The AATG program brings together 34 investigators from ten departments, representing a
broad spectrum of research backgrounds and expertise, ranging from basic research to drug discovery, who are
engaged in basic and translational, disease-oriented research focusing on autoimmune/autoinflammatory
conditions.
challenging
Our faculty are either current or up-and-coming leaders in their fields, which will foster intellectually
discourse, a firm understanding and working knowledge of the principles and applications of cutting-
edge research technologies, and exciting thesis research. The goal is to provide our trainees with the skill set to
succeed as independent and creative investigators in the constantly evolving world of biomedical research.
The AATG provides predoctoral students with critical career skills to effectively communicate their discoveries,
and students will be strongly encouraged to participate in regional, national and international meetings. The
training curriculum will also emphasize scientific rigor, methods for appropriate data management/analysis/
validation, biosafety, conflict resolution, and ethical conduct. The AATG physician-scientists will enable our
trainees to engage with leaders in adjacent clinical sites to better understand the diseases we hope to cure. The
AATG faculty further serve as role models and provide attractive opportunities for women, economically
disadvantaged and underrepresented minorities to encourage the pursuit of careers in basic scientific research.
These goals will help meet future challenges and societal needs in biomedical research.

Public health relevance
PROJECT NARRATIVE In the past two decades, we have seen a paradigm shift in our understanding of the mechanisms underlying autoimmune and autoinflammatory diseases. To continue generating key insights and developing novel therapeutic strategies will require the next generation of scientists to have broad, multidisciplinary understanding and training in the latest advanced technologies. The Training in the Molecular Basis of Autoimmunity and Autoinflammation develops predoctoral investigators in these crucial areas by bringing together highly skilled and collaborative training faculty from multiple disciplines, with the ultimate goal of developing effective treatments, and eventually cures, for these debilitating diseases.